Bench to Beside and Back translational immuno-onocology-Cures

Four CCR projects are currently supported by this Cancer Moonshot Bench to Bedside and Back award: 1) TME informed NK cell therapy for pediatric sarcomas, led by Rosandra Kaplan (CCR) and Timothy Cripe (Nationwide Children's Hospital). 2) Targeting neuroendocrine tumors with DLK1 directed immunotherapy, led by Nitin Roper (CCR) and John Maris (CHOP). 3) B2B and Back: CD22 and CD19/22 CAR immunotherapies for childhood leukemia, led by Naomi Taylor (CCR) and Crystal Mackall (Stanford). 4) Alternative splicing of CD22 following Inotuzumab, led by Nirali Shah (CCR) and Andrei Thomas-Tikhonenko (CHOP). Project 2 published on the "Identification of the Notch ligand DLK1 as an immunotherapeutic target and regulator of tumor cell plasticity and chemoresistance in adrenocortical carcinoma".